UNC Research Training Program in Respiratory Diseases and Critical Care

Project Summary/Abstract
This proposal for a new T32 Program titled “UNC Research Training Program in Respiratory Diseases and
Critical Care” at The University of North Carolina-Chapel Hill supports 6 postdoctoral trainees with M.D.,
M.D./Ph.D. or Ph.D. degrees for research training in lung disease, emphasizing a joint training program for
Medicine and Pediatric trainees. The Program provides multidisciplinary training in basic, translation and clinical
research within the pulmonary and critical care divisions of the Departments of Medicine and Pediatrics and our
three Research Centers devoted to understanding lung health and disease. Our Program offers a Training
Faculty of 48 trainers (38 mentors, 8 junior mentors and 2 co-mentors) from 7 clinical (2) and basic science (5)
departments in the School of Medicine. M.D. trainees will enter at years 3-5 in their clinical and research training,
designed to provide them with skills required for a leadership career in academic pulmonary medicine. Ph.D.
trainees will typically enter in the second year of their post-doctoral fellowship, and they will be well integrated
into the basic, translational and clinical aspects of their project. Each trainee will have a scholarly oversight
committee that includes mentors from varying disciplines who will facilitate their scientific growth and career
development, including grant writing and leadership skills. Each trainee will be welcomed into a DEI culture, will
take workshops, and will become embedded in this culture. Each area of lung research is multidisciplinary in
nature and emphasizes a broader knowledge of the basic, translational, clinical and impact implications for each
trainee's question. Areas of research include cystic fibrosis, primary ciliary dyskinesia, idiopathic bronchiectasis,
cell and molecular biology of airway epithelia in health and disease, leukocyte kinetics and clinical research in
COPD, control of airway inflammation, inflammatory and innate immune responses during ARDS and bacterial
and viral infections, clinical trials, comparative effectiveness research, analyses of qualitative narrative data, and
large cohort studies in critical care, basic and translational proteomics of airways and alveoli, the airway
microbiome in health and disease, the responses to injury by physical, chemical, and microbial environmental
agents, and clinical and basic science studies in asthma. Novel programs that exemplify the multi-disciplinary
nature include ARDS and Critical Care Research, the CF Research Program, and Combustion-induced
Bronchitis in the Military, each of which require cross-disciplinary interactions amongst a wide range of expertise
to accomplish their goals. Clinical studies will be integrated with basic observations using translational
physiologic, biochemical, molecular and genetic technologies, and -omics approaches and will provide training
in state-of-the-art –omics and other basic technologies, bioinformatics, database design, use and analyses, and
statistical interpretation. Emphasis is on mechanisms underlying lung diseases in pediatric and adult populations
and development of novel therapeutic strategies. Our Program provides an opportunity for trainees to develop
as scientists and become independent investigators and leaders within the national community.

Public health relevance
Project Narrative Our Program will provide M.D., M.D./Ph.D. and Ph.D. post-doctoral fellows with state-of-the-art research training in common and rare lung diseases affecting the pediatric and adult populations. Lung diseases such as lung infections including bacterial and viral pneumonia, acute respiratory distress syndrome, genetic diseases of the airways including cystic fibrosis and primary ciliary dyskinesia, chronic obstructive pulmonary disease, asthma, environmental lung diseases, and lung diseases with an environmental component such as allergic lung diseases are common and are associated with devastating morbidity, mortality and use of health care dollars. Our Program offers 48 highly qualified faculty in 7 departments to serve as mentors and co-mentors for our trainees and provides a highly multidisciplinary pulmonary scientific community that creates an outstanding opportunity for trainees to develop their technical and intellectual abilities as scientists and to become independent investigators within the national community, pursuing important questions about the pathogenesis and course of lung diseases in pediatric and adult populations and developing novel therapies.